ChicAgo Center for Health and EnvironmenT (CACHET)

1. OVERALL: ABSTRACT
This is the revised submission of the first competing renewal proposal for the “ChicAgo Center for Health and
EnvironmenT (CACHET)” – the first NIH P30 Environmental Health Sciences (EHS) Core Center in the Chicago
area established in 2017 with an equal partnership between the University of Chicago (UofC) and the University
of Illinois at Chicago (UIC). With synergistic partnership between the two universities with complementary
strengths, CACHET promotes multidisciplinary EHS research among clinician, laboratory, and population
scientists to evaluate, delineate, and ultimately reduce environmental health related disparities among residents
of Chicago and beyond. The continuation of a dedicated EHS research center in Chicago is warranted by deep-
rooted environmental and social inequalities and their associated health outcomes across population sub-
groups. In this context, the CACHET mission is to elucidate biological, social, and behavioral
underpinnings between relevant urban environmental exposures and human disease and translate the
findings to reduce health inequities within our communities. Our overall goal is to mitigate environmental
health-related disparities among residents of Chicago and beyond. While there was some EHS research
at both institutions prior to the establishment of CACHET; over the past 3.5 years, CACHET has integrated this
research, brought researchers together, formalized and steered intra- and inter-institutional collaborations, and
significantly enhanced EHS research support infrastructure in the Chicago area. Specifically, CACHET has
established Biomarkers and Microbiome Cores, a dynamic Pilot Project Program (PPP), a vibrant Community
Engagement Core (CEC), and a highly translational Integrated Health Sciences Facility Core (IHSFC) – all new
to the Chicago area. Within this short time frame, and despite the COVID-19 pandemic, CACHET has made
positive impacts on interdisciplinary and inter-institutional collaborations, multi-sectorial partnerships among
community/city/state agencies, and translational EHS discoveries. Leveraging our progress and lessons learned
so far, and responding to reviewers’ critique of our first resubmission, we are moving forward by i) streamlining
CACHET focus group structure to improve interactions, synergy, and translation, ii) better leveraging the UofC-
UIC complementarity and institutional infrastructure to maximize CACHET efficiency, iii) responding to the P30
RFA new emphasis on translational EHS research, iii) addressing NIEHS strategic mission, and, iv) addressing
the trans-NIH initiative on structural racism on EHS research. We have revamped the CEC with new leadership
and a community-focused agenda; we formed a “Environmental Biomarkers Core (EBC)” by merging the
previous ‘Biomarkers’ and Microbiome’ Cores with enhanced access to other institutional Omics Cores (not
funded by CACHET); we refined the IHSFC to augment its services to access and leverage large cohorts
established and led by CACHET members; and we have enhanced diversity in EH research capacity in Chicago
through pilot projects and tailored career development.

Public health relevance
OVERALL NARRATIVE ChicAgo Center for Health and EnvironmenT (CACHET)”, the first NIEHS P30 environmental health sciences core center in the Chicago area, was established in 2017 as a collaboration between the University of Chicago and University of Illinois at Chicago. Leveraging the experience and progress made over the past 3.5 years, CACHET will continue to promote multidisciplinary environmental health research among clinician, laboratory and population scientists from two Chicago area universities with complementary strengths and structure to understand, evaluate and ultimately reduce environmental health related disparities among residents of the region and beyond.